Immersive and Interactive VR Platform for Quantitative Telehealth Rehabilitation of Rare Diseases

To develop a multi-modal virtual reality environment for remote use, enabling physicians and healthcare providers to guide rare disease patient therapy while automatically obtaining crucial health metrics.